Training Program in Molecular and Cellular Biology

ABSTRACT
The primary goal of this successful predoctoral Training Program in Molecular and Cellular Biology at UC Davis
is to provide Program Trainees, who represent the most qualified PhD students in molecular and cellular biology,
with the breadth of knowledge and research training, and career skills, that will prepare them for their own
successful careers in the national biomedical workforce. Training is provided by 65 Trainers in 16 academic
departments, with wide-ranging interests including genetics, biochemistry, structural biology, cell, molecular and
developmental biology, physiology and neuroscience. Trainers are selected from the top molecular and cellular
biologists on campus, each with an active research program and a successful track record of mentoring. Trainees
are selected from the most qualified graduate students across five different Graduate Groups. Training is
accomplished by integrating Graduate Group coursework and PhD thesis research in individual laboratories with
a set of coherent training activities developed by this Program. These activities are aimed at enhancing not only
the skills needed to perform modern molecular and cellular biology research at the highest level, but also a highly
transferable skill set applicable to any high-level career. Trainees and other Program-associated PhD students
participate in activities aimed at honing research strategies and techniques, especially as related to enhancing
quantitative approaches to molecular and cellular biology, research rigor and reproducibility, critical thinking
abilities, oral and written communication skills, and the responsible conduct of research, and in providing career
development and networking activities. Trainees also receive in depth exposure to diverse careers in the national
biomedical workforce, and assess their skills, interests and values relative to these careers through their
Individual Development Plans (IDPs). We believe that this combination of discipline-specific training in Trainers’
research laboratories, and the interdisciplinary scientific training in cutting-edge molecular and cellular biology
and career development offered by this Training Program, will make our trainees better prepared for the changing
technical and intellectual climate faced by the next generation of basic biomedical scientists. This Training
Program requests support for 16 predoctoral student slots to support 8 Trainees for 2 years each, during the
second and third year of their PhD training, a modest increase given the success that this Training Program has
demonstrated. Institutionally, UC Davis has made a major commitment to establish the faculty and infrastructure
in molecular and cellular biology to achieve these training goals, and to support such training in the form of this
Training Program through substantial institutional support for the future. This high quality interdisciplinary training
in molecular and cellular biology, broadened research perspective and professional skill set will enable Trainees
to have successful careers and a significant impact on the national health and science agendas.

Public health relevance
NARRATIVE The purpose of the Training Program in Molecular and Cellular Biology is to provide high quality predoctoral training in molecular and cellular biology. This is achieved through a coherent set of training activities enhance the interdisciplinary research skills and professional development of a diverse group of future contributors to the national biomedical workforce. Through these activities this Training Program will continue to significantly contribute to achieving the mission of the NIH.